Research Triangle Center of Excellence in Regulatory Science and Innovation

ABSTRACT
The rapid emergence of innovative technologies, therapeutics, and other FDA-regulated products have outpaced
the ability to effectively appropriate them for public benefit. Doing so hinges on the capability to expeditiously
evaluate these products and effectively monitor them once on the market. However, methodologies for pre-
market evaluation through laboratory testing and clinical trials for drugs, devices, and biologics and for post-
marketing surveillance of all FDA-regulated products have not kept pace, and key gaps in knowledge exist that
would inform regulatory decision making in many areas. In the face of these pressing needs, the Research
Triangle Center of Excellence in Regulatory Science and Innovation (Triangle CERSI) will provide a one-stop-
shop accelerator to meet FDA’s current and evolving needs in regulatory science and a generative community
for regulators, academia, industry, and other stakeholders. A collaboration of the University of North Carolina at
Chapel Hill, Duke University, North Carolina State University, and North Carolina Central University, all in close
proximity, the Triangle CERSI represents a broad network of investigators and national and international
collaborators that bring unique and diverse expertise and resources for regulatory science, including but not
limited to novel approaches in statistical methodologies, machine learning and artificial intelligence, imaging, in
silico trials, pediatric pharmacology, patient reported outcomes (PRO), population science, and safety
assessment across the lifespan, and other areas. The Triangle CERSI includes two Schools of Medicine, a
School of Pharmacy, two Schools of Nursing, a School of Public Health, a College of Veterinary Medicine, a
leading historically Black university, a national Center for Virtual Imaging Trials, and the Duke Clinical Research
Institute, and leverages relationships with nearby companies and organizations in the Research Triangle Park.
The Triangle CERSI has three specific aims: 1. Conduct regulatory science projects in collaboration with FDA to
deliver major advances in regulatory science and rapidly address a broad range of major, specific, and emerging
challenges in response to FDA needs. 2. Establish robust CERSI Core infrastructure to develop, propose,
support, enable, and monitor execution of CERSI research projects to facilitate rapid achievement of project
deliverables; partner Oak Ridge National Laboratory provides support for data access, computation, and
resource sharing. 3. Expand support of the Triangle CERSI and extend its impact through regulatory science
information sharing activities, including efforts to diversify the regulatory science workforce. The Triangle CERSI
will actively share results and newly developed tools and resources with the FDA, research community,
stakeholders, and our institutions’ students and trainees. Together, our overarching goal is to provide an
abundance of essential new information, infrastructure, and tools to shorten the drug and device development
process, to advance public health, and to inform FDA activities in ways that complement other CERSIs and
contribute to achieving the goals of the national CERSI program.

Public health relevance
PROJECT NARRATIVE To address the FDA’s need for expanded regulatory science capabilities, the Research Triangle Center of Excellence in Regulatory Science and Innovation (Triangle CERSI) will provide a generative community for regulators, academia, and industry while serving as a one-stop-shop accelerator to meet current and evolving needs of regulatory science. The Triangle CERSI represents a collaboration of four leading academic institutions in North Carolina that are in close proximity (the University of North Carolina at Chapel Hill, Duke University, North Carolina State University, and North Carolina Central University). The Triangle CERSI aims to fully deploy our broad, collective expertise and close collaborations with FDA personnel to create and expedite utilization of important new knowledge in regulatory science and to provide an infrastructure of flexible and innovative toolsets to enrich the efficiency and value of FDA activities as part of the national CERSI program.